Research Training on Alcohol Etiology and Treatment

DESCRIPTION (provided by applicant): The purpose of this Research Institute on Addictions (RIA) program is to provide specialized postdoctoral training for individuals seeking to pursue a career in alcohol research. The proposed program focuses on providing quality research training in two (2) primary areas: (1) etiology and course of alcohol use and misuse and (2) treatment for alcohol use disorders. The goal of the program is to produce scientists who are thoroughly trained to teach and conduct systematic research on these and related topics. The program is characterized by several strengths. First, an interdisciplinary approach is used as the framework for the training program. The Core and Associated Faculty include representation of such diverse yet complementary fields as psychology, sociology, epidemiology, behavioral neuroscience, criminal justice, social work, internal medicine, and psychiatry. Second, the faculty are all experienced and productive researchers. All are actively involved in relevant research endeavors, and the majority are serving as Principal Investigator (PI) on federally-funded projects. Third, RIA provides a variety of supports requisite to the research training enterprise, including a specialized library, a state-of-the-art computer center, an animal care facility and associated laboratories, laboratories for human studies, and an outpatient clinical research treatment center. The faculty provides training for six postdoctoral fellows. Trainees are assigned a specific preceptor, based on their research interests. The preceptor provides training in conceptualization, methodology, and ethics of research in the trainee's primary area of study. The program also includes several required seminar components: Foundations of Interdisciplinary Alcohol Research, Current Alcohol Research (including a monthly "journal club"), Grant Writing, and Professional Issues and Career Development. Trainees meet quarterly with the Training Grant Supervisory Committee and attend RIA's Seminar Series, which includes statistics workshops.